Anti-Mullerian Hormone Actions to Control Primate Folliculogenesis

PROJECT SUMMARY
Anti-Müllerian hormone (AMH) plays a key role during ovarian follicular development. We have advanced
our understanding of the dynamic expression, direct action, and physiological role of AMH during
folliculogenesis in rhesus macaques since the initial award of the project. Data suggest that AMH is produced
heterogeneously by developing follicles and exhibits stage-dependent regulatory effects by promoting preantral
follicle growth and preventing antral follicle maturation. Stage-specific AMH modulation improves follicle growth
and maturation in vitro to generate competent oocytes. Therefore, further research is warranted to elucidate
the downstream molecular and cellular events regulated by AMH at the specific stages of follicular
development, as well as the potential for modulation of AMH actions to improve ovarian function and female
fertility. Our preliminary studies show that (a) AMH administration in vivo promotes preantral follicle growth,
resulting in the increased number of antral follicles in the ovary; (b) primordial follicle activation and growth to
the preantral stage is achieved by ovarian tissue culture after cryopreservation; and (c) preantral follicles are
maintained in a state of physiological hypoxia. AMH has the potential to regulate cell cycle progression by
limiting actions of hypoxia-inducible factor, and to control cellular energy production by inducing creatine
biosynthesis and metabolism under hypoxia. Thus, studies will be performed to test the hypothesis that stage-
specific modulation of AMH actions facilitates follicular development in vivo and in vitro, which in turn improves
fertility outcomes. Aim 1 will evaluate the impact of AMH priming on ovarian response to gonadotropin
stimulation during IVF (in vitro fertilization). AMH will be administered in vivo in macaques at advanced
reproductive age or with poor response to controlled ovarian stimulation (COS). The COS protocol will then be
performed to evaluate IVF efficacy. Aim 2 will examine the effect of AMH modulation on in vitro maturation of
follicles from cryopreserved macaque and human ovarian tissue. Vitrified-warmed ovarian cortex will be
cultured to induce primordial follicle activation and growth to the preantral stage. Preantral follicles will then be
isolated and cultured with AMH modulation for oocyte maturation. Aim 3 will determine the molecular
mechanisms whereby AMH regulates cell proliferation and energy production during follicular development.
Macaque preantral follicles will be cultured at 5% O2 with AMH supplementation or knockdown. Factors
regulating cell cycle progression and creatine biosynthesis/metabolic pathway components will be analyzed.
The proposed studies will provide important insight into the mechanism of stage-dependent AMH actions
in regulating follicular development and ovarian function using a nonhuman primate model that is an excellent
surrogate for understanding reproductive processes in women. The findings will allow for developing protocols
for optimizing IVF process, advancing options for female fertility preservation, and defining AMH-mediated
regulation of cell cycle and energy metabolism during folliculogenesis.

Public health relevance
PROJECT NARRATIVE The proposed research is to investigate the stage-dependent AMH actions in regulating follicular development and ovarian function, and to evaluate stage-specific AMH modulation in facilitating follicle growth and maturation to improve fertility outcomes. The results will provide critical insight into defining the mechanism of AMH-mediated regulation in cell cycle and energy metabolism during folliculogenesis, developing protocols for optimizing IVF (in vitro fertilization) process, and advancing options for female fertility preservation.